Cancer Center Administration

PROJECT SUMMARY: Cancer Center Administration
Mindy Roberts, M.A., Associate Director of Administration
The Knight Cancer Institute (KCI) is a matrix organization within Oregon Health & Science University (OHSU).
Under the leadership of KCI Director Brian Druker, M.D., the KCI Administrative team has been an integral part
of its success. The past several years have brought tremendous positive change to the cancer institute, including
the appointment of world-renowned scientists to serve as KCI Senior Leaders, successful construction and
occupation of three new buildings, and a tightly orchestrated transition for faculty and staff. We have undergone
enterprise-wide strategic planning resulting in a new five-year Strategic Plan. We have appointed key leaders in
new areas of Precision Oncology, Precision Early Detection, Community Outreach and Engagement, Cancer
Research Training, Medical Director of Clinical Research, and Shared Resource Management. Finally, KCI
Administration has supported the expansion of our membership by recruiting 56 new cancer researchers and
implementing a new grant, publication, and membership management system.
The KCI Administration team plays a critical role in providing resources and expertise to support the strategic
initiatives and ongoing operations of the KCI. Working to prevent duplication and ensure integration and
coordination with the larger OHSU structure, Mindy Roberts, M.A. Associate Director of Administration, ensures
the KCI Administrative office meets the needs of the KCI. She also acts as a liaison to OHSU central service
groups, divisions, and departments across campus. Key activities overseen by the KCI Administrative office
include 1) fiscal and grants management; 2) shared resource support in collaboration with the Associate Director
of Shared Resource Management; 3) CCSG management, including membership processes, budget oversight,
progress reporting, and renewals; 4) space management; 5) planning and evaluation activities; 6) strategic
communications and event coordination; 7) business development and commercialization support; 8) information
technology support and development; 9) general administration, human resources, and organizational
development; 10) community outreach and engagement support in collaboration with the Associate Director of
Community Outreach and Engagement; 11) education and training support in collaboration with the Associate
Director of Cancer Research Training; 12) pilot project administration and management of developmental funds;
and 13) faculty recruitment management.